Impact of sex and age on non-visual light input that affects sleep and circadian rhythms

Project Summary/Abstract
Light is processed in the eye for both visual and non-visual [i.e., non-image-forming (NIF)] pathways. NIF pathway targets
include circadian rhythms, hormones (e.g., melatonin, which is important in sleep and circadian rhythms), heart rate, EEG,
mood, and pupillary light response physiology. NIF pathway targets are central to many circadian, sleep, psychiatric, and
neurologic health outcomes whose risks and progression vary by sex and age. It is therefore important to document
whether the response to light input to the NIF pathway and its targets differ by sex and age because of their potential
contribution to the pathogenesis, risk, and/or severity of some disorders; this should facilitate targeted diagnosis,
monitoring, and treatment strategies.
Intrinsically photosensitive retinal ganglion cells containing melanopsin are the primary sensors for NIF processing, whose
response to light stimuli’s wavelength, intensity, and duration differ from those of rods and cones. We will test the
hypothesis that the responsiveness of the melanopsin pathway depends on sex and age. A method for probing the
response of the melanopsin pathway uses the post-illumination pupil response (PIPR) which can be documented using
commercially available pupillometers in sessions lasting less than an hour by trained staff with results available almost
immediately. PIPR is reported to be altered in individuals with circadian sleep/wake, psychiatric, and neurologic disorders
that have different distributions by sex and age. There are four problems with prior studies using PIPR that severely limit
interpretation and translation of the prior work: (i) not designed to test for sex and age effects; (ii) considerable variation in
stimuli and analysis methods; (iii) stimuli that may not be melanopsin-pathway specific; and (iv) no documentation of time-
dependent response variation by sex and age. Sex or age differences would require appropriate study population
composition to avoid confounding. The most frequently used test of the melanopsin pathway for NIF-influenced circadian
rhythms is light-induced melatonin suppression. This method requires multiple hours of data collection over two nights, is
onerous for participants, has expensive assay costs, and does not provide results in close-to-real time.
We will test for sex and age differences in PIPR in 48 healthy individuals (1:1 for F:M; and 1:1:1 for age groups 18-40,
40-60 and 60-85 years). Individuals will have (i) pupillometry with specific durations, light wavelengths and intensities
chosen to primarily affect the melanopsin pathway (M+) or not (M-) at three different clock times; (ii) melatonin suppression
testing using M+ and M- stimuli from portable light boxes; and (iii) documentation of circadian phase and sleep timing. We
will calculate multiple measures of PIPR (including pupil size at 6 sec, time-varying changes in pupil size and others); these
will be correlated with melatonin suppression, circadian phase, and sleep timing.
As a resource for standardization of methods, we will make available our data cleaning and analyses programs on a public
website. Increased use of pupillometry could be beneficial for further investigations of NIF pathway-related sex- and age-
related differences in health and disease; clinical applications including diagnosis and monitoring before disease symptoms
emerge; and design and testing of personalized targeted interventions including retina-based therapies and/or light exposure.

Public health relevance
Narrative Light through the eye affects both image-forming (e.g., vision) and non-image-forming physiology (e.g., sleep, circadian rhythms, melatonin, and the pupillary light response), which are important for health and resilience. We will test whether pupil responses to different light stimuli are affected by a person’s sex and age.